Chromosome dynamics and organizations necessary for faithful chromosome segregation

PROJECT SUMMARY
Cell division is a conserved process by which replicated chromosomes are equally partitioned into two daughter cells.
Errors in this process often result in gains or losses of chromosomes, known as aneuploidy, which can cause and
promote tumors and developmental diseases. During mitotic progression, chromosomes dynamically change their
positions in a force-dependent manner via forces generated at kinetochores, macro-molecular protein structures built
on centromeric chromatin that serves as platforms for microtubule assembly. While chromosome territories, regions
preferentially occupied by specific chromosomes in interphase nuclei, have been established and are known to be
involved in gene regulation and genomic protection, the presence and function of chromosome organization in mitosis
have not been adequately explored. Our long-term goals are to characterize “mitotic chromosome territories” in
mammalian cells and to uncover the function behind spatiotemporal regulation of both chromosome organization and
kinetochore dynamics in ensuring faithful chromosome segregation. In this proposal, we will test the hypothesis that
there exist chromosome organizations in mitosis as in interphase nuclei using a super-resolution microscopy method
we recently developed, which will allow us to identify full sets of individual chromosomes and determine their spatial
organization in mammalian cells. If there exist mitotic chromosome territories, we will explore how and when they are
established and their evolution throughout mitosis. We also hypothesize that major mitotic defects (unaligned
chromosomes, lagging chromosomes, and chromosome bridges) are associated with improper chromosome
organization. We will examine this hypothesis by identifying which chromosomes are involved in each defect with
increased frequency and determine their positionings. Mitotic cells have two major pathways for correcting mitotic
errors, mediated by Aurora A or Aurora B kinases. Both kinases are spatially regulated and phosphorylate a highly
conserved microtubule-binding kinetochore protein, Ndc80/Hec1, to destabilize improper microtubule bindings for
promotion of error correction and regulation of SAC (spindle assembly checkpoint) activity. Aurora A-mediated error
corrections require proximity of erroneous chromosomes to the spindle poles, where Aurora A is concentrated. On
the other hand, Aurora B-mediated error corrections depend on dynamic deformations of kinetochores. These
suggest that mitotic chromosome positioning, coupled with kinetochore dynamics, orchestrate the cooperation
between Aurora A and Aurora B-mediated error correction machineries. We will dissect the contributions of
chromosome positioning and kinetochore dynamics towards Aurora A and Aurora B error corrections using force-
calibrated microneedles and a semi-automated, quantitative microscopy analysis software that we recently developed
called the 3D speckle analyzer (3D-Speckler). Our proposed work will provide new, mechanistic insights into mitotic
chromosome organization and its contribution toward ensuring the integrity of chromosome segregation, which will
contribute towards developing better therapeutic and detection strategies for cancer and developmental diseases for
improved patient outcomes.

Public health relevance
PROJECT NARRATIVE Cell division is an essential process by which replicated chromosomes are equally segregated to daughter cells, however this process is prone to errors, which can result in chromosomal instability and lead to cancer and developmental diseases. There are potential molecular mechanisms contributing towards faithful chromosome segregation that have not yet been adequately explored, one of which is the evolution and maintenance of chromosome organization throughout mitosis. Our proposed work of defining the spatial organization of mitotic chromosomes and kinetochores required for accurate chromosome segregation using innovative imaging methods is of fundamental importance to public health because a clear understanding of the mechanisms underlying faithful chromosome segregation will contribute towards developing better therapeutic and detection strategies for cancer and developmental diseases for improved patient outcomes.